Elevated homocysteine in African American Prostate Cancer: Association with Diet and Dietary practices, evaluating its biomarker potential, and characterizing its tumor promoting function

Project Summary/Abstract
Our research plan's long-term objective is to reduce the disproportionate effects of prostate cancer on African
American men. In our published and yet to be published studies, we have found that increased levels of a
metabolite homocysteine were significantly associated with men with higher West African ancestry who have
elevated levels of the clinical prostate cancer marker prostate-specific antigen and who have been diagnosed
with prostate cancer. Our work further reveals significantly reduced levels of vitamin B6 and unique dietary
practices in African American men who are at high risk of developing prostate cancer. Also, we show a possible
role for elevated homocysteine in promoting metastasis (or spread) of the prostate tumors to the bone, which is
predominantly seen in African American patients.
Based on these findings, in this application, we propose determining the association between different dietary
practices and elevated levels of homocysteine and the likelihood of having prostate cancer in African American
men. In addition, we propose to determine the biological role of elevated homocysteine in promoting the growth
and development of African American prostate cancer. We will also evaluate the ability of combined levels of
three metabolites: homocysteine, methionine, and vitamin B6, in plasma, to detect prostate cancer early in
African American men.
This study's impact relies on understanding the role of diet and dietary patterns in contributing to prostate cancer
risk and the potential to develop healthy lifestyle interventions (e.g., dietary modification, vitamin B6
supplementation, etc.) to mitigate the risk of developing PCa in AA men. In the longer term, homocysteine and
vitamin B6 could be set as markers to screen AA men at higher risk of developing PCa.

Public health relevance
Project Narrative At present, it is not known how the prostate cancer metabolome contributes to health disparities. The information gleaned from this proposal could rapidly revolutionize current diagnostic, prognostic, and therapeutic approaches by revealing the biological underpinnings of prostate cancer health disparity. This proposal investigates how altered metabolism in African-American Prostate Cancers promotes tumor progression and how the knowledge can be used in the future to develop diet based interventions and early detection markers for African American men.